Comprehensive Analysis and Multi-Omics Data Integration for Cancer-Related Studies

Project Summary/Abstract
I am a principal data scientist and bioinformatics manager of The Experimental and
Computational Genomics Core in the Sidney Kimmel Comprehensive Cancer Center
(ECGC) at Johns Hopkins University. This Core offers comprehensive bioinformatics
support to members of both the Cancer Center, the Bloomberg~Kimmel Institute for
Cancer Immunotherapy (BKI), and the Convergence Institute at Johns Hopkins
including both standard informatics and innovative analysis pipeline development. To
this work, I bring expertise in multi-omics data analysis methods through my role leading
the DNA methylation analysis in several tumor types for The Cancer Genome Atlas
(TCGA). In my role as bioinformatics manager of ECGC, I oversee day-to-day
bioinformatics services and supports the bioinformatics needs of investigators in areas
of data integration, annotation, high-throughput and spatial data analysis. In this
capacity, I develop bioinformatics software tools to support many cancer research
activities. I collaborate with a number of investigators across different research
programs in the cancer center. I highlight the key collaborations in this application as
illustrative of my research portfolio. For example, I played a key role in development of
the comprehensive analysis of T-cell receptor sequencing data for the FEST (Functional
Expansion of Specific T cells) assay. I also perform multi-omic analyses of changes in
the tumor microenvironment due to immunotherapy and correlate those changes with
clinical outcomes. With the support of this R50 award, I will extend my current pipeline
development to state of the art single cell spatial technologies and data integration
techniques and train future bioinformatics analysts to benefit various cancer-related
studies throughout the cancer center.

Public health relevance
Project Narrative Comprehensive bioinformatic analysis and multi-omics data integration is an essential part of a wide variety of cancer-related studies such as biomarker discovery for cancer immunotherapy or the role of epigenetics in cancer-specific regulation. This application is aimed to support the development of state of the art bioinformatics analysis pipelines through my role as principal data scientist and bioinformatics manager of The Experimental and Computational Genomics Core in the Sidney Kimmel Comprehensive Cancer Center. The support of the R50 award will enable broader access of comprehensive bioinformatic expertise provided by the Experimental and Computational Genomics Core for diverse cancer-related studies by members of the Sidney Kimmel Comprehensive Cancer Center, the Bloomberg~Kimmel Institute for Cancer Immunotherapy, and the Convergence Institute at Johns Hopkins.